NALOXONE AND NEONATAL ADAPTATION IN THE HUMAN

CDMAS USE ONLY. To study the effect of blockade of endorphin by naloxone on the blood level of stress hormones (catecholamines) during labor and delivery in newborn infants.